Regulation of Synaptic Rhythmicity by Astrocytic Clock

Cognitive deficits such as learning and memory impairments are common in people subjected to chronic
disturbance of the circadian cycle due to shift work, travel, or genetic dysregulation of the circadian clock.
Epidemiological studies have revealed a global rise in cognitive disorders with circadian disruptions comorbidity
such as depression, and Alzheimer’s disease, stressing the need to identify the causal relationship between
these phenomena. However, the molecular mechanisms linking the circadian cycle and cognitive performance
in health and disease remain largely unresolved. Neuronal synapses are the cellular basis for learning and
memory processes. Synapse number, activity, and expression levels of synaptic proteins show rhythmic time-
of-day-dependent changes, yet how these changes are regulated by the circadian clock is poorly understood. A
growing body of work supports a critical role for the glial cells, astrocytes in normal clock function. Astrocytes are
important synaptic regulators, and key for establishment and maintenance of memory and learning. Yet, how the
astrocytic clock regulates synaptic rhythmicity and related cognitive performance has not been thoroughly
examined. This critical gap in knowledge must be addressed in order to understand not only the fundamental
functions of the astrocytic clock, but also to characterize the regulatory mechanisms that control circadian
changes in synaptic levels. This application will define the role of astrocytic clocks in regulating synaptic
rhythmicity and subsequent learning and memory behaviors in three aims. Aim 1 investigates how the astrocytic
clock expressed in brain regions responsible for cognitive processes (e.g., cortex, and hippocampus; outside the
central clock located in the suprachiasmatic nucleus (SCN)), affects time-of-day-dependent changes in synapses
and cognitive performance. Aim 2 investigates how the astrocytic clock is regulated by calcium activity to
influence synaptic rhythmicity. In Aim 3, we test the hypothesis that astrocyte-derived synapse-regulating factors
are rhythmically produced to facilitate time-of-day-dependent modulation of synapses. Successful completion of
these aims will uncover the role of astrocytic clock in regulating synaptic and cognitive rhythms, and reveal
strategies for future manipulation of synaptic rhythmicity through astrocyte-targeting, to restore clock-associated
cognitive deficits prevalent in neurological disorders.

Public health relevance
Successful completion of the proposed experiments will characterize the role of astrocytic circadian clock in regulating synaptic rhythmicity and cognitive performance. There is a strong comorbidity between disruptions to the circadian cycle, and cognitive impairments, yet the mechanistic link is not well understood. We will examine how astrocytic molecular clock regulates time-of-day-dependent changes in synapse number and activity, determine the mechanisms controlling its function, and identify the rhythmic astrocytic factors that can be targeted to correct clock-related cognitive deficits.